Development of Novel Biphilic Phosphorus Catalysts via Computational Modeling and Multidimensional Analysis

PROJECT SUMMARY/ABSTRACT
The discovery of potent pharmaceutical agents requires expedient access to a wide range of diverse molecular
architectures, and the chemical tools available to the medicinal chemist both enable and limit this venture. Over
the past half century, transition metal-catalyzed cross-coupling has grown into a powerful strategy for organic
synthesis. However, the use of the d-block elements presents specific disadvantages, including low acceptable
metal content in pharmaceutical products and susceptibility to unproductive coordination by polar medicinally-
relevant functional groups. Thus, there has been a recent surge in interest in developing cross-coupling catalysts
containing the naturally abundant main group elements of the p-block. Mechanistic understanding of the
reactivity of main group catalysts lags far behind that of transition metal catalysts, and synthetic applications
remain limited. One particularly promising approach for main group catalysis is to utilize the P(III)⇌P(V) redox
couple as one would employ the analogous redox couples of transition metal catalysts. To develop improved
biphilic catalysts for phosphorus redox cycling chemistry, a more complete mechanistic understanding of the
factors affecting catalyst performance is necessary. Towards this end, the proposed research will employ two
distinct approaches to catalyst development: multivariate regression analysis to correlate phosphetane structure
with desired redox properties, and computational modeling to guide the rational design of a novel class of boron-
and silicon-containing phosphetanes with reduced frontier orbital energy gaps. The detailed study of these
catalysts will provide valuable insights into the ability of phosphorus-based catalysts to facilitate carbon-
heteroatom bond formation, enabling the development of an allylic amination reaction of immediate medicinal
relevance.
This research proposal supports and aligns with the fellowship goals by requiring new skills to be learned in
inorganic synthesis, mechanistic study, and computational modeling that complement previous training in
synthetic organic methods development. The Radosevich lab provides an ideal research environment uniquely
suited to facilitate training in these areas, as evidenced by their pioneering efforts in the development of
phosphorus-catalyzed reactions. Prof. Radosevich’s personal commitment to supporting postdoctoral
researchers in their development into independent investigators ensures that the professional training goals will
be achieved. Lastly, MIT, as one of the most productive research institutions in the world, provides the resources
and equipment necessary to carry out the research proposed.

Public health relevance
PROJECT NARRATIVE The discovery and development of novel small molecule pharmaceuticals depends on medicinal chemists’ ability to rapidly construct and derivatize molecular scaffolds. Though remarkable advances in transition metal- catalyzed cross-coupling have revolutionized organic synthesis within drug discovery, low thresholds for metal contamination in pharmaceutical products—as well as the susceptibility of d-block elements to coordination with medicinally relevant, polar functional groups—has fueled interest in developing alternative catalytic methods utilizing main-group elements. This proposal describes the design of novel nontrigonal phosphorous catalysts to enable the development of a medicinally-relevant C–N cross-coupling, employing both computational modeling and multidimensional analysis to guide catalyst optimization and discern key mechanistic details.